Anatomical, Neural, and Computational Constraints On Sensory Cross-Modal Plasticity Following Early Blindness

Project Summary/Abstract
Early blindness results in dramatic neuroplasticity within the human brain; anatomical and functional organization
is altered at almost every level, ranging from neurotransmitter balance to neural function. I plan to combine
psychophysics, computational functional magnetic resonance imaging (fMRI), diffusion-weighted MR imaging
(dMRI), and MR spectroscopy (MRS) to investigate the anatomical, neural, and computational constraints of
plasticity following early blindness. This proposal is driven by the hypothesis that cortical plasticity resulting from
early blindness may share many of the same underlying mechanisms as ‘neuronal recycling, whereby the
development of novel cortical functions (such as reading in sighted individuals) relies on the ‘recycling’ of
evolutionarily older circuits that originally evolved for different, but similar, functions.
I plan to examine this idea in the context of cross-modal plasticity within the visual motion area hMT+. Area
hMT+, which processes visual motion in sighted individuals, responds selectively to auditory motion in early blind
individuals. In Aim 1, using a combination of dMRI and fMRI, I will examine if the cross-modal responses to
auditory motion within hMT+ in early blind individuals co-localizes with pre-existing anatomical connectivity
between hMT+ and the auditory motion area right planum temporale (rPT). In Aim 2, I will test the hypothesis
that auditory motion processing in EB is influenced by the spatiotemporal tuning within hMT+, using a
combination of psychophysics and fMRI. In Aim 2, I will also examine whether the recruitment of hMT+ for
auditory motion processing in early blind individuals results in a loss of sensitivity to auditory motion in rPT.
Finally, in Aim 3, using a combination of psychophysics and fMRI, I will see if auditory motion responses in hMT+
can be explained by a classic model of divisive normalization that has been extensively used to model hMT+
visual motion responses in sighted individuals. By including MRS GABA measurements, I will further test whether
the lower signal to noise associated with auditory rather than visual motion input results in an adaptive reduction
in suppression, mediated by lower GABA concentrations.
The training will focus on computational fMRI, dMRI, and MRS, which will augment my background in
characterizing diverse human perceptual experiences using psychophysics and modeling. My mentors at the
University of Washington (Drs. Ione Fine, Ariel Rokem, and Scott Murray) will provide excellent training in all the
techniques used in this proposal. The award will provide an important opportunity for me to uniquely position
myself in the field as an independent researcher with a strong research program that investigates the
neuroanatomical basis of plasticity following visual deprivation.

Public health relevance
Project Narrative Changes in the human brain following early blindness have been widely documented, but our understanding of the mechanisms underlying this remarkable neuroplasticity is very limited. My goal is to examine the anatomical, neural, and computational constraints that allows blind individuals to meet the extraordinary challenge of learning to navigate and interact with the environment using remaining senses. This will not only facilitate the development of targeted rehabilitation programs for blind individuals, but will also help us understand the processes underlying acquisition of specialized skills (including reading and arithmetic) during development.